XRAY ABSORPTION SPECT OF MANGANESE IN PHOTOSYNTHETIC OXYGEN EVOLVING COMPLEX

Significant progress, highlighted by recent crystallographic structual determinations, has been made in understanding the structure of the polynuclear metal centers in the complex nitrogenase enzyme. The presence of a Mo-Fe-S cluster is known and its ligation within the protein established. Important questions remain that include i) relationship of the FeMoco structure outside of, to that within, the protein; ii) understanding the role of homocitrate and of pH-dependent effects on nitrogenase; iii) determining where and how substrate and inhibitors bind; and iv) establishing highly accurate metrical details for the FeMoco both within and outside the protein. X-ray absorption spectroscopy (both edge and EXAFS) using SR is well-suited to providing insights into electronic and metrical structure of selected atomic sites.